NUCLEAR MEDICINE COMPUTER SYSTEM

This contract will result in the Nuclear Medicine Department having data acquisition and processing systems (DAS's) and a central host computer (host system) interconnected to form a Nuclear Medicine Computer System for use in clinical studies, including data management and archiving. The DAS's will be associated with the various nuclear scanners in the Department.